The Cholangiocarcinoma Conference: Molecular Drivers, Microenvironment, and Precision Medicine

Project Summary/Abstract
Cholangiocarcinoma (CCA) is a macro-molecularly diverse hepato-biliary tract malignancy that
accounts for approximately 3.0% of gastrointestinal malignancies and between 10% to 20% of
primary liver cancers. Over the past 10-20 years, CCA has become the focus of heightened
interest and concern, due in large part to the now well recognized increasing incidence of
intrahepatic CCA in various countries around the world, as well as with CCA’s globally high
mortality rates also rising in several areas of the world, including the USA. Most CCA patients
are diagnosed with advanced disease, where treatment options are limited and overall, 5-year
survival rates are dismal. However recent advances in a growing number of targeted therapies
and clinical trials are offering some hope for improving survival outcomes for advanced CCA
patients. To our knowledge, this FASEB Scientific Conference represents the first-of-its kind 4-
day in person comprehensive scientific meeting solely devoted to CCA. It brings together a
diverse group of senior and talented early career investigators to critically assess important
areas of current and evolving basic, translational, and clinical research focused on addressing
the major challenges that continue to limit progress towards achieving significant improvements
in CCA prevention, clinical management, and patient survival outcomes. Key topic areas that
will be addressed include (1) the challenges of inter- and intra-tumoral heterogeneity, (2) the
roles of the microbiome and tumor microenvironment in affecting disease progression,
therapeutic resistance, and immunosurveillance, (3) cellular origins, lineage, and genomic
relationships between CCA and hepatocellular carcinoma, (4) identification of novel and more
effective biomarker signatures for early CCA detection and for monitoring prognosis and
treatments; (5) advances in “multi-omics” for personalizing therapies, (6) innovative preclinical
modeling for CCA drug discovery, (7) current and emerging trends in CCA personalized
medicine, and (8) exploring new technologies and approaches for CCA therapies. Additional
important aims of this much needed conference involve providing a collegial and collaborative
environment that supports early career investigator development, promotes scientific cross-talk
between different scientific and clinical disciplines, mentors underrepresented researchers
actively engaged or interested in joining the CCA research community, and encourages
networking with international CCA research consortiums and patient advocacy organizations.
The ultimate aim is to advance new and effective strategies for greatly reducing the human
impact of this highly fatal malignancy.

Public health relevance
Project Narrative This inaugural in-person FASEB Scientific Conference brings together a diverse group of senior and talented early career investigators and trainees to address important areas of current and evolving basic, translational, and clinical research focused on addressing the critical challenges that continue to limit progress towards achieving significant improvements in cholangiocarcinoma (CCA) prevention, clinical management, and patient survival outcome. It is also very likely to have important biological and clinical implications relevant to the rising increase in CCA incidence and mortality rates in the USA that appear to be linked to emerging fibroinflammatory risk factors like viral hepatitis, obesity and/or diabetes that are very frequent and shared by other more common cancers (i.e., hepatocellular carcinoma, pancreatic ductal adenocarcinoma, colorectal cancer).